Development and characterization of an inducible model for myocilin POAG

Primary Open Angle Glaucoma (POAG) is the leading cause of irreversible blindness affecting over 57 million
people worldwide. Progressive loss of retinal ganglion cells (RGCs) and degeneration of optic nerve axons is
the pathological hallmark of glaucoma. Elevated intraocular pressure (IOP) due to dysfunction of trabecular
meshwork (TM) is the most significant and the only known modifiable risk factor for glaucoma. Understanding of
the pathological mechanisms of glaucomatous TM dysfunction and neurodegeneration is limited due to lack of
robust and faithful mouse model that mimics both TM dysfunction and glaucomatous neurodegeneration.
Developing a mouse model of known genetic cause of POAG represents an ideal strategy to understand the
pathophysiology of POAG. Mutations in myocilin (MYOC) gene are the most common genetic cause of POAG.
Using TARGATT site-specific knockin strategy, we developed a Cre-inducible transgenic mice that expresses
DsRed-tagged Y437H mutant of human myocilin (Tg.Cre-MYOCY437H). This technology utilizes serine integrase,
PhiC31 (ΦC31) to insert any gene of interest (a single copy) into a preselected intergenic and transcriptionally
active genomic locus (Hipp11), which has been engineered with a docking site. This allows stable and site-
specific transgene integration. In our preliminary studies, we observed that a single intravitreal injection of helper
adenovirus (HAd) 5 expressing Cre selectively induced human mutant myocilin protein in mouse TM.
Importantly, Ad5.Cre injection resulted in significant and sustained IOP elevation in Tg.Cre-MYOCY437H mice. We
hypothesize that TM-specific expression of mutant myocilin leads significant and pronounced IOP elevation and
glaucomatous neurodegeneration in Tg.Cre-MYOCY437H mice. The major goals of this application are to induce
mutant myocilin expression in TM using HAd5-cre injections and to characterize glaucoma phenotypes of
Tg.Cre-MYOCY437H mice. In Aim 1, we will determine whether HAd5-mediated Cre induces mutant myocilin
expression in TM and elevates IOP in Tg.Cre-MYOCY437H mice. In Aim 2, we will determine whether HAd5-Cre-
induced IOP elevation leads to glaucomatous neurodegeneration in Tg.Cre-MYOCY437H mice. Our proposal will
utilize highly innovative approaches. These include use of efficient and site-specific gene knockin strategy for
generation of transgenic mice, a comprehensive investigation of outflow pathway, RGC functional and structural
loss, optic nerve damage and damage to the visual centers of the brain. Our proposed studies will develop much
needed mouse model of POAG that faithfully replicate all features of glaucoma.

Public health relevance
Project Narrative The successful completion of this project will lead development of mouse model of glaucoma to aid insights into molecular pathways that cause trabecular meshwork dysfunction, elevation of intraocular pressure and neurodegeneration in glaucoma, a leading cause of irreversible vision loss. Furthermore, successful completion of this project will provide mouse model to develop novel treatment strategies for glaucoma.